Molecular Mechanisms of HFpEF-associated Atrial Fibrillation

PROJECT SUMMARY
It is said that heart failure with preserved ejection fraction (HFpEF) is the single greatest unmet need in
cardiovascular medicine. Patients with HFpEF are uniquely predisposed to atrial fibrillation (AF), a common
rhythm disturbance that is associated with worse clinical outcomes. In other words, AF and HFpEF co-segregate,
substantially exacerbate one another, and represent a prevalent and unique clinical challenge without effective
therapies.
Metabolic diseases, such as obesity, diabetes, and hypertension, are common comorbidities for both HFpEF
and AF, suggesting that metabolic disturbance serves as a common mechanism underlying both conditions.
We recently developed and validated a uniquely informative murine model of HFpEF and unveiled
mechanisms never reported previously in heart disease. These animals are predisposed to AF, just as are
patients with HFpEF. Further, we have collected preliminary data revealing that AMPK signaling is impaired in
the atria of these mice and is associated with atrial remodeling similar to changes observed in HFpEF patients.
If confirmed, this is a novel mechanism of disease-triggered AF, one that does not involve tissue fibrosis, etc.
Here, we propose to test the central hypothesis that impaired AMPK signaling contributes to pathological
atrial remodeling in HFpEF, and modulating this pathway will attenuate atrial pathology and AF predisposition in
HFpEF.
Specifically, we will delineate the role of AMPK in HFpEF-associated atrial structural and electrical remodeling,
focusing on atrial myocyte hypertrophy, Cx40-mediated atrial myocyte communication, and HCN4-mediated
ectopic automaticity. In a translational aim, we will determine the effect of AMPK activation on attenuating atrial
remodeling and AF predisposition

Public health relevance
PROJECT NARRATIVE Heart failure with preserved ejection fraction (HFpEF) is increasing in prevalence worldwide. HFpEF patients are predisposed to atrial fibrillation (AF), a rhythm disturbance that exacerbates HFpEF and is associated with worse clinical outcomes. We have uncovered evidence of a novel mechanism of HFpEF-associated AF, and we propose here to define and manipulate underlying mechanisms.